Center to Improve Chronic disease Outcomes through Multi-level and Multi-generational approaches Unifying Novel Interventions and Training for health EquitY (The COMMUNITY Center)

PROJECT SUMMARY/ABSTRACT:
Improving multiple domains of cardiometabolic health (CMH) through contextual behavioral interventions has
the potential to substantially reduce persistent chronic disease disparities. Sleep is critical for preserving CMH
and is amenable to intervention in real-world settings. Although sleep health, in conjunction with other lifestyle
behaviors, can improve CMH through complementary or synergistic pathways, most existing lifestyle change
programs focus solely on diet and physical activity. We will conduct a community-based cluster randomized trial
to evaluate the impact of incorporating a multidimensional sleep health intervention into the BWELL4LIFE
program, an ongoing 4-week program for promoting CMH through healthy diet and physical activity, delivered
by peer health educators at faith-based organizations and community centers in underserved NYC
neighborhoods (Aim 1). The enhanced 6-week intervention, SLEEP2BWELL, will include the following additional
components: 1) two sleep health education and group coaching sessions, 2) self-monitoring and motivational
enhancement using a Fitbit, and 3) addressing prevalent environmental barriers to healthy sleep in urban settings
such as noise, light, heatwaves, with a novel and timely extension to address indoor air pollution based on input
from our community partners. We will randomize 14 community sites into the intervention (SLEEP2BWELL) or
usual care (BWELL4LIFE) group, enrolling an average of 15 participants per site for an expected sample of 210.
We will collect objective measures of sleep and physical activity throughout the study, and assess diet and CMH
outcomes at baseline, 10 weeks (primary endpoint), and 24 weeks (long-term follow-up to assess sustainability
of the intervention’s effect). We hypothesize that SLEEP2BWELL will enhance the effectiveness of BWELL4LIFE
leading to greater improvements in CMH, including reduced blood pressure (primary outcome) improved health
behaviors (sleep, diet, physical activity) and adiposity markers (secondary outcomes), as well as better glycemic
control and inflammatory and allostatic load indicators (exploratory outcomes). To ensure the successful
completion and future expansion of this work, we will use mixed methods to understand implementation
determinants and outcomes, guided by implementation science frameworks (Aim 2). This first-of-its-kind
effectiveness-implementation study, addressing individual level behaviors and factors and upstream influences
and leveraging key behavior change and community engagement strategies, will investigate the integration of
sleep health into a multi-behavior lifestyle change intervention aimed at addressing CMH disparities in
community settings. Our innovative multilevel intervention will inform scalable sustainable community health
approaches and public health policy, consistent with NIH’s priorities to improve sleep health and CMH disparities
through advancement in novel multilevel bundled behavioral interventions.

Public health relevance
NARRATIVE: The goal of this project is to reduce the burden of multiple chronic conditions by improving cardiometabolic health in economically disadvantaged New York City neighborhoods of predominantly Black, Hispanic, and immigrant communities with a high prevalence of hypertension, obesity, and type 2 diabetes and an increasing co- occurrence of multiple morbidities. The SLEEP2BWELL cluster randomized trial will employ a blended effectiveness-implementation design to evaluate the impact and implementation of a multicomponent and multilevel lifestyle intervention, targeting sleep health in addition to healthy diet and physical activity and addressing upstream barriers, on cardiometabolic health. Findings can offer broad implications for reshaping ongoing lifestyle programs and public health policy and informing scalable and sustainable community and system-level changes for addressing persistent cardiometabolic health inequities.